SOFTWARE DEVELOPMENT TO CONVERT TOPOLOGY FILES FROM AMBER TO GROMACS FORMAT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. To aid in the dissemination of the GLYCAM force field, a computational tool is being developed that will automatically convert file formats so that either the AMBER or GROMACS simulational packages may be employed to run MD simulations with the GLYCAM force field.